Macrophages Modulate Osteoclast Activity through Plasmin Regulation

Abstract
Proper bone healing following tooth extraction is critical to restore function. Complications can lead to infection,
prolonged pain, and fewer treatment options for patients. During healing, macrophages are recruited to the site
of inflammation, which peaks 24 hours after injury and persists through day 7. Additionally, macrophage
presence has been shown to support bone formation and efferocytosis (phagocytosis of apoptotic cells) is
associated with bone healing. Osteoclastic resorption is another essential step in early stages of osseous
wound healing. Patients treated with anti-resorptives are at risk for osteonecrosis of the jaw (ONJ), and the
possibility of developing ONJ dramatically increases with tooth extraction. Preliminary data by the project
investigator showed a significant up-regulation of plasminogen activator inhibitor 2 (protein: PAI2, gene:
SerpinB2) in macrophages when they were exposed to apoptotic bone cells, and not when exposed to non-
bone cells. PAI2, a member of the serpin superfamily, inhibits plasminogen activators resulting in reduced
plasmin concentrations. Plasmin has an established role as a proteolytic enzyme in the fibrinolytic system.
Plasmin also cleaves substrates in the extracellular matrix and is implicated in degradation of the osteoid layer
covering the bone surface, thus increasing susceptibility to osteoclastic resorption. The overall goal of this
project is to study the integration of the fibrinolytic system and osteoimmunology in oral wound healing. It is
hypothesized that efferocytosing macrophages produce PAI2, which inhibits plasminogen activation
resulting in decreased bone resorption and delayed wound healing.
Two aims are proposed: 1) to identify the conditions of PAI2 production by macrophages in response to
apoptotic osteoblast engulfment, and 2) to determine the effect of PAI2 deficiency on osteoclastic activity and
wound healing. To accomplish these aims, first an in vitro co-culture system that allows for macrophage
engulfment of apoptotic bone marrow cells will be used. This will be a valuable tool to measure increases in
PAI2 gene and protein changes in a controlled environment. Furthermore, we will delineate whether PAI2 is
intracellular or secreted. Next, we will determine the dependence of oral socket bone healing on PAI2 using a
murine knock out model. We anticipate there to be an effect on osteoclast activity due to the role of plasmin in
initiating bone resorption. Therefore, we will focus evaluation of these samples on measures of osteoclastic
activity. Understanding bone microenvironmental mechanisms for recovery broadens our knowledge of basic
bone biology and pathology, providing early targets for future therapeutic interventions. When completed, the
experiments described in this proposal will be novel in establishing the role of PAI2 in bone biology and
homeostasis, providing new mechanistic insights into the bone microenvironment and signaling pathways. In
addition, these studies will be foundational in establishing scientific experiences that will launch a successful
scientific career for the project principal investigator.

Public health relevance
Project Narrative Improper function of the dentition can make normal breathing, eating, and speaking a challenge; however, the oral cavity is often ignored when evaluating biological activity of novel drugs, pathways, and cellular targets of research. Defective oral extraction site healing leads to prolonged discomfort and compromised restoration of function, and is often seen in patients who are already experiencing medical complications. The objective of this study is to more clearly define the role of an integral immune system cell (the macrophage) and its link to oral bone wound healing in order to facilitate better optimization of current strategies and new options for patients.